Biophysical force affects type 1 alveolar epithelial cell-mediated regulation of the pulmonary matrisome and lung development

PROJECT SUMMARY/ABSTRACT
This proposal delineates a five-year individualized training plan that will promote an independent
scientific career to study the pathogenesis of bronchopulmonary dysplasia (BPD), which is the most common
sequalae of prematurity and impacts the patient throughout the lifespan. Specifically, the scientific program of
the candidate will focus on how biophysical force affects type 1 alveolar epithelial cell (AT1)-mediated
regulation of the pulmonary matrisome within the developing lung. The applicant is an Instructor within the
Division of Neonatology and Department of Pediatrics at the Children’s Hospital of Philadelphia and has
previous training in cell and molecular biology with an emphasis on oxidative stress. Over the past several
years, she has worked as a clinical research fellow in the laboratory of Dr. Edward Morrisey, a world-renowned
expert in developmental biology and lung regeneration with a phenomenal record of mentorship success. The
goals of this current proposal are to acquire expertise in transcriptomics, epigenetics, and mechanobiology that
will help define her future career as an NIH-funded independent investigator. To meet these goals, her and Dr.
Morrisey have developed a robust training program with coursework and workshops offered by the University
of Pennsylvania and have put together a diverse advisory committee to aid her in her scientific and career
development goals. Together with the outstanding environment offered by CHOP and UPenn, she is well-
poised to launch into a productive and innovative research career as a physician-scientist.
Recent clinical evidence suggests that the incidence of BPD is increasing as the thresholds of viability
are challenged, but the multifactorial etiology of disease pathogenesis has remained elusive. In addition, there
are no treatment options which can prevent BPD or can promote pulmonary regeneration in affected neonates.
The aims in this proposal will address the central hypothesis that biophysical force promotes AT1 cell
regulation of the alveolar proteosome, in part through upregulation of TGFβ signaling leading to expression of
a constellation of matrisome members that are essential in maintaining alveolar health and function during
neonatal lung growth and maturation. In Aim 1, the candidate will identify how elevated mechanical stress
impacts AT1 cell-mediated regulation of the pulmonary matrisome in both in vivo mechanical ventilation and in
vitro cellular stretch models and examine if its effects are attenuated with loss of TGFβ. Aim 2 will characterize
the effects of mechanical ventilation on the developing lung more globally, with a single-cell approach to
examine the transcriptomic and epigenetic regulatory networks as well as intercellular communication that
predisposes to altered development and BPD. Successful completion of these aims will provide new insight
into how AT1 cells translate applied biophysical force into changes of their own matrisome program to affect
their local environment and communicate broadly with other cell compartments to impact the normal lung
developmental programming.

Public health relevance
PROJECT NARRATIVE Bronchopulmonary dysplasia (BPD) is a lung disease that affects infants born extremely premature, especially those that require mechanical ventilation. Type 1 pulmonary epithelial (AT1) cells are large gas-exchanging cells that are placed at a crucial interface of the outside environment and the underlying developing lung and have been recently found to be key contributors to the pulmonary matrisome. This proposal will identify how biophysical force on AT1 cells impacts matrisome-related gene expression and communication across the developing lung that predisposes to BPD and related comorbidities.